Personalized experiences to inform improved communication for minorities with Life Limiting Illness (LLI)

Disparities in palliative care for minorities with LLI exist because of gaps in knowledge around patient centered psychological, social, and spiritual palliative care interventions. Patient-­ centered palliative care communication interventions must be informed by the perspectives of patients who are living each day with LLI. Storytelling interventions are an effective way to communicate a patient’s cultural values and beliefs. Yet, there is a lack of research about how to efficiently and effectively integrate the patient’s story into the EHR. The central hypothesis of this proposal is that the implementation of a patient-­centered storytelling intervention with minority patients will result in improved patient-­provider communication. For the K99 Phase, specific aim 1 is to identify barriers and facilitators for the storytelling intervention from the perspectives of the key stakeholders-­minority patients with LLI and acute care bedside nurses-­through patient and nurse exit interviews;? and field analysis of EHR interface use and end-­user surveys of the nurses. Specific aim 2 is to conduct usability testing, applying a user-­task-­system-­environment evaluation process to determine essential requirements for integration and use of the patient-­centered story into the EHR, from the perspective of an important end-­user: the acute care bedside nurse. For the R00 Phase, specific aim 1 is to establish acceptability, feasibility, and potential effect size of the patient-­ centered storytelling intervention for hospitalized minority patients with LLI. Specific aim 2 is to compare the effects of the storytelling intervention to usual care for the primary outcome of quality of communication and for secondary outcomes of anxiety, depression and psychosocial illness impact. The expected outcome of K99 phase will be the refinement of a storytelling intervention. The expected outcomes of R00 phase will be completion of a proof-­ of-­concept study of the storytelling intervention. This proposal will build a program of patient-­ centered research with racial and ethnic minority populations and provide the foundation for future R01 applications for developing, testing, and tailoring patient-­centered communication interventions to improve QoL for minority patients living with LLI.

Public health relevance
Project Narrative The proposed research is relevant to public health because disparities in palliative care for minorities with life limiting illness exist due to lack of integration of culturally sensitive psychological, social and spiritual care interventions. Patient-centered communication interventions that are integrated into the electronic health record creates possibilities of incorporating the psychological, social and spiritual values and beliefs of the minority patient with life limiting illness. Outcomes from this work will provide incremental development and testing of a patient-centered communication intervention in palliative care that take into account the perspectives of an ethnoculturally diverse group of minorities living with life limiting illness.